EFFECTS OF KETOCONAZOLE AND AROMATASE INHIBITOR ON OVARIAN GONADAL ACTIVITY

This study will determine if the combination of ketoconazole, an antibiotic, and an aromatase inhibitor together will suppress ovarian and adrenal steroidogenesis within five days. Recruitment is ongoing.